Cancer Research Career Enhancement and Related Activities

PROJECT SUMMARY/ABSTRACT–Cancer Research Career Enhancement and Related Activities
A strategic goal for the SJCCC is to develop a well-trained, diverse biomedical workforce through research
education, training, and career-development activities that promote understanding of the biology and treatment
of childhood cancer. Research shows that early intervention strategies, beginning in elementary and middle
school, are essential to enhancing the biomedical careers pipeline, especially for students from
underrepresented backgrounds. The SJCCC provides the financial support, leadership and institutional
infrastructure to support this comprehensive biomedical training pipeline, initiating efforts in elementary school
and continuing through the faculty level. Career enhancement activities are led by the Associate Director for
Education and Training, Dr. Gerard Zambetti, who also serves as an institutional Vice President and Director
of the Academic Programs Office in Biomedical Sciences, allowing a seamless integration of SJCCC and
institutional efforts. Dr. Zambetti coordinates the efforts of a qualified group of staff supporting elementary
education and outreach, pre- and postdoctoral education and training, and faculty career development activities.
He also works closely with the Center Director, Senior Leadership and Program Leaders to develop, evaluate
and oversee an extensive portfolio of career enhancement activities across this spectrum. For example, the
SJCCC Cancer Education and Outreach Program has worked with thousands of K-5 students and teachers,
particularly in underrepresented communities, to inspire pursuit of research careers, and our NCI-funded
Pediatric Oncology Education Program has trained more than 1200 students, 23% of whom are
underrepresented minorities and 87% of whom have gone on to receive doctoral degrees. Dr. Zambetti and
SJCCC members were also instrumental in the development and launch of the St. Jude Graduate School in
Biomedical Sciences, a new PhD program focused on translational research that matriculated its first class of
12 students in 2017. The SJCCC also launched the annual Science Scholars of Tomorrow Symposium to provide
high school students and teachers insight into cutting-edge pediatric cancer research and the Clinical Shadowing
Program for postdoctoral fellows to develop experience in how laboratory research relates to the treatment and
care of pediatric cancer patients. In addition, the Center initiated new grant-writing workshops for postdoctoral
fellows and faculty to support development of their research careers. Future plans for the next project period
include the continued growth and accreditation of the St. Jude Graduate School, the addition of a new Masters
program in Global Health, establishment of a certificate-based program for physicians and healthcare providers
(St. Jude Global Academy), expansion of our K-12 educational efforts, and a focused initiative to expand
NIH/NCI-funded training and educational programs (e.g., R25, T32, K awards) for students and fellows.